SUPPORT FOR THE ANNUAL MEETING FOR THE RESEARCH SOCIETY ON ALCOHOLISM (RSA)

The Research Society on Alcohol (RSA) Annual Meeting is the premier annual scientific
meeting involving all areas of alcohol research. In addition to biological/preclinical
aspects, it also covers medical/clinical, and psychosocial research. The RSA meeting is
held annually, and previous meetings (42) have been held mostly in the continental US,
although some meetings have also been held in Hawaii and Canada (Vancouver,
Montreal). Also, the 2021 meeting is being planned as a joint meeting between RSA and
the International Society for Biomedical Research on Alcoholism. The location of these
meetings will provide an attractive opportunity for scientists from around the U.S.A.
along with others around the world to present and discuss their research. The meetings
will have a large impact on alcohol research in the U.S., and the outcome of the
research presentations and discussion will advance the field. The program for each
meeting will feature topics that are highly relevant to the alcohol research community
and provide opportunities for discussion of existing and new collaborative research. The
research presentations will be in the form of symposia, roundtables, and workshops that
will be proposed by the membership of RSA. The RSA Program Committee will select
the proposals with the highest scientific merit and innovation. In addition, numerous
poster sessions will be held. The RSA has made an effort to recruit and retain new
investigators in the field by highlighting their work as well as providing professional
development activities, and this will continue for the 2021-2025 meetings. Since RSA is
a stable, established organization with annual meetings, this application is for 5 years of
funding (support for the 2021-2025 meetings). This application specifically requests
funds to offset expenses for young scientists (predoctoral and postdoctoral within 4
years of their terminal degree) to attend these important meetings. Funds are requested
for travel and registration fees. Some administrative costs are also requested. The
specific aim of this grant is to provide travel and registration assistance for students and
young investigators to attend the annual RSA meeting. The overall goal is to provide
information to those individuals who are interested in learning more about current
research in the alcohol field with the possibility of pursuing alcohol research as a career.

Public health relevance
PROJECT NARRATIVE Alcohol use disorders are major public health problems in most parts of the world including the United States. This request is for funding to allow young scientists to attend the 44th through 48th Annual Meeting of the Research Society on Alcoholism (RSA). The meeting outcome will greatly advance the treatment, prevention, and understanding of alcoholism in the U.S. and throughout the world, and it will also help to retain trainees and young investigators in the field.